Tracking B cell:Antigen Interactions for HIV-1 Vaccine Development

Project Summary/Abstract
Despite 40 years of research, no HIV-1 vaccine exists. More than 1 million people acquire HIV-1 every year and
600,000 people died in 2023 due to AIDS-related illnesses. To be effective, an HIV-1 vaccine must elicit a durable,
broadly neutralizing antibody (bNAb) response that provides protection against diverse viral variants. Sequential
immunization is a promising vaccination strategy for eliciting bNAbs. However, available sequential protocols
have been unsuccessful at eliciting durable and high titers of bNAbs that can protect against HIV-1 infection.
This proposal aims to understand how the plasma cell compartment develops during sequential immunization to
inform the design of vaccines that induce long-lasting protection. Aim 1 of this proposal will use a novel, AAV-
based B cell tracking technology to characterize the plasma cell compartment in the bone marrow of mice after
sequential immunization. This technology tracks the antigenic history of B cells and, therefore, can provide
information regarding the antigenic requirements for plasma cell development. Aim 1 will also test whether the
existence of non-neutralizing plasma cells from early stages of sequential immunization inhibit the establishment
of bNAb-expressing plasma cells in the bone marrow. This will deepen our understanding of how the plasma cell
compartment is established and persists after HIV-1 sequential immunization. These results may be applicable
to other immunization strategies that use multiple immunizations to elicit the desired antibody response. Aim 2
of this proposal seeks to uncover the mechanisms of plasma cell differentiation after immunization. B cell:antigen
interactions underpin many aspects of B cell biology including activation, interaction with other lymphocytes, and
selection within germinal centers. Despite its importance, it is now known how many times a B cell interacts with
antigen during immunization. Aim 2 will adapt the AAV-based B cell tracking technology to quantify the number
of B cell:antigen interactions a B cell experiences. In Aim 2, this approach will directly test the influence of B
cell:antigen encounters on B cell fate. This will result in new information and approaches for directing B cells
towards a desired fate. Altogether, this proposal will result in new knowledge about B cell fate decisions and
contribute new opportunities to design immunization protocols that better elicit durable, bNAb responses for HIV-
1 vaccination.

Public health relevance
PROJECT NARRATIVE Despite decades of research, no HIV-1 vaccine exists. The most successful HIV-1 immunization protocols that elicit neutralizing antibodies against HIV-1 do not elicit a serum antibody response that is strong enough to protect against infection. The goal of this proposal is to understand the cellular mechanisms that lead to durable and high magnitude antibody responses upon immunization to identify guidelines for vaccine design.